Focused Imaging as a Novel Diagnostic Strategy for Aortic Stenosis

Aortic stenosis (AS) is a valve condition that affects over 12.6 million adults and causes an
estimated 102,700 deaths each year. Many patients with AS do not know about the diagnosis
because it is difficult to diagnose with a stethoscope. It is estimated that there are over 560,000
undiagnosed cases of AS in the United States alone. When patients with symptomatic AS are
not treated, 50% will die in 2 years. We have developed a method to automate the diagnosis of
AS from cardiac ultrasound imaging using machine learning. This represents a new way to
diagnose AS. In this proposal we will improve these networks to reliably identify severe AS
patients that should be referred for evaluation. Additionally, we will train the networks to work
with portable handheld ultrasound devices and we will study how to implement this tool in
primary care offices to screen high risk patients. By developing and validating innovative
machine learning (ML) methods for diagnosing AS we will establish tools to improve the
identification and treatment of this life-threating condition.

Public health relevance
Aortic stenosis (AS) is a common heart valve condition that can be deadly. It is difficult to diagnose AS though there are effective treatments for this condition. The goal of our research is develop and validate machine learning methods to automate the diagnosis of AS using imaging from handheld ultrasound devices and improve treatment of this life-threating condition.